Mechanistic studies of protein kinases

PROJECT SUMMARY
This research focuses on a class of enzymes that are integral to human health, protein kinases. The
most frequent post-translational modification of proteins is phosphorylation, and these modifications made by
protein kinases. These additions are an integral component of the information flow controlled by numerous
signaling pathways that control a myriad of cellular decisions ranging from cell growth to immune responses.
Disruption of these pathways leads to diseases ranging from cancer to developmental defects. The goal of this
research program is to determine the molecular mechanisms that regulate the activity of protein kinases. We
will use the Hippo pathway, which controls decisions of cell fate and number, as a model system to investigate
different mechanisms that modulate the activity of protein kinases. We will combine biophysical, biochemical,
structural bioinformatics, and cellular approaches to examine how the activity of these enzymes is tuned. This
work will address fundamental gaps in our understanding of protein kinase regulation, decipher the molecular
mechanisms regulating the activity of the protein kinases in the Hippo pathway, and investigate novel routes of
Hippo pathway modulation. The molecular insight gained from this research will accelerate the development of
targeted therapies to block inappropriate kinase activity which will be broadly applicable to multiple diseases.

Public health relevance
PROJECT NARRATIVE Fundamental decisions regarding cell fate or number are controlled by signaling pathways, and when these pathways are disrupted they lead to disease. This work aims to understand the molecular mechanisms controlling integral components of these pathways, protein kinases. The proposed work will provide key insight into the function of protein kinases that will accelerate the development of therapeutics including those with anti-cancer or tissue repair properties.